Investigating the effects of adolescent binge drinking on prelimbic somatostatin circuitry

PROJECT ABSTRACT
Binge drinking during adolescence has been identified as a potential risk factor for alcohol use disorder (AUD)
in adulthood. Despite this, the precise neuronal populations which are altered by adolescent drinking, and which
may contribute to changes in adulthood drinking, have not been fully characterized. Somatostatin (SST)-
expressing neurons in the prelimbic (PL) cortex are altered by adult binge drinking in animals models, and
manipulating the activity of these neurons can reduce binge drinking. The goal of this proposal is to determine
the role of SST neurons following adolescent binge drinking, as well as during escalated adulthood alcohol
consumption following adolescent exposure. The first set of experiments will use whole-cell patch-clamp
electrophysiology and fiber photometry to understand how adolescent alcohol use affects SST neurons in the PL
cortex. The second set of experiments will use behavioral and chemogenetic manipulations to identify a causal
role for SST neurons in changes in adulthood alcohol consumption after adolescent binge drinking.

Public health relevance
PROJECT NARRATIVE Adolescent alcohol use, particularly during early adolescence, is a risk factor for excessive alcohol use in adulthood; however, neuronal changes underlying increased alcohol use have not been fully characterized. This project will use cutting-edge techniques to investigate the function of a particular neuronal population and its role in increased adulthood drinking following adolescent alcohol exposure.